YAP and IRF2BP2 regulation of cardiomyocyte innate immune responses

Cardiomyocytes (CMs) are building blocks and function units of the heart, and their dysfunction or loss
is the root of heart failure. Similar with other specialized innate immune cells, CMs have their own
innate immune molecular machinery. Ischemic or non-ischemic pathological stress activates CM
innate immune signaling pathways, which stimulate pro-inflammatory cytokine release and reactive
oxygen species (ROS) production. These innate immune responses are beneficial for defending CMs
against pathogen invasion and for tissue repair, but can also cause myocardial damage. The ultimate
goal of this project is to define new molecular mechanisms that regulate CM innate immune
responses, which will shed light on the pathogenesis of pathogen or non-pathogen related
cardiomyopathy. Damage/danger-associated molecular patterns (DAMPs) initiate innate immune
responses by binding to pattern recognition receptors, and one of the best-characterized signaling axis
is TLR4/NF-kB pathway. The Hippo-YAP pathway is crucial for heart development and cardiac
regeneration, and disturbances in Hippo-YAP have been implicated in a range of heart diseases.
IRF2BP2 (interferon regulatory factor 2 binding protein 2) is a transcription co-factor little studied in the
heart. We recently found that YAP regulates CM innate immune responses by blunting TLR4/NF-kB
signaling, and that IRF2BP2 is crucial for restraining TLR4 expression in the heart. In this project, we
will test the hypothesis that YAP and IRF2BP2 are suppressors of CM innate immune responses. We
propose the following two aims. Aim 1. Define the role of YAP in CM innate immune responses. In this
aim, we will determine whether YAP regulation of CM innate immune responses depends on its
transcriptional activity. Additionally, we will develop a novel YAP modRNA delivery system. We
previously showed that transiently activating YAP with intra-myocardial delivered aYAP modRNA
reduced heart injury. However, the in situ delivery method limits aYAP modRNA's clinical application.
Here, we will test the efficacy of CM targeted and nano-particle packaged aYAP modRNA in a murine
cardiac ischemia/reperfusion model. Aim 2. Define the role of IRF2BP2 in CM innate immune
responses. In this aim, we will perform IRF2BP2 gain- and loss-of-function studies to define its role in
CM innate immune responses. Additionally, we will investigate the molecular mechanism of how
IRF2BP2 regulates CM innate immune responses. Using the new Irf2bp2 knock-in mouse line we
have recently generated, we will perform IRF2BP2 ChIP-Seq to identify its direct targets. This proposal
is innovative and significant, as it focuses on dissecting the basic molecular mechanisms that underlie
CMs innate immune responses, and it aims to develop new therapeutic strategies for reducing
myocardial infarction injury.

Public health relevance
NARRATIVE Cardiomyocytes (CMs) are the building blocks and function units of the heart, and their loss or dysfunction is the root of heart failure. Pathologic stress within the heart activates CM innate immune responses, which are beneficial for tissue repair, but can also cause cardiac inflammation and myocardial damage including CM dysfunction or death. In this proposal, we will determine the roles of YAP and IRF2BP2 in the regulation of CM innate immune responses, and evaluate the potency of these two proteins as novel druggable targets for treating acute myocardial infarction disease.